Assessment of the Immune-mediated Protection and Pathology Conferred by Candidate Filovirus Vaccines

This agreement will utilize animal models to explore the cause of immunopathology in the microenvironment of the vaccinated animal lung following infection with Ebola virus via the aerosol route.